Neuroinflammation, Epigenetics and Male Vulnerability

The developing brain is punctuated with critical periods for specific organizational and remodeling events that
are guided by sensitivity to endogenous and exogenous stimuli. Perturbations in those stimuli create nodes of
vulnerability for dysregulation with enduring consequences and increased risk for neurodevelopmental disorders.
Identifying previously unknown critical periods and the parameters that define them are essential steps in the
quest to reduce or ameliorate the impact of neurodevelopmental disorders and improve the health of children.
Two pervasive features are the heightened risk to males and the deleterious consequences of neuroinflammation
as the brain grows. Rarely, however, are these two features considered together. We have previously described
roles for the innate immune cells of the brain, microglia and mast cells, in guiding synaptic development in the
preoptic area/hypothalamus during a critical period for hormone-mediated sexual differentiation of the brain.
Mast cells, unlike microglia, are not unique to the brain but instead occupy a wide variety of niches throughout
the body where they subserve numerous functions, many of which are still being discovered and include
surprising roles as tissue remodelers. Mast cells in the brain remain poorly understood, particularly during
development. The potential for distinct temporally regulated populations within the brain has never been
considered. We propose that possibility here and hypothesize there are two distinct populations of mast cells
in the developing brain with common and divergent functions in health and disease. These populations
are found in the POA/hypothalamus and hippocampus and share the common feature of peaking in density
across the first week of life and then precipitously declining. The tightly regulated peak and decline in mast cells
is reminiscent of a critical period, which has been established for the POA/hypothalamus. However, the two
populations diverge along several lines, the most striking being the high proliferative capacity of the hippocampal
mast cells with a complete absence of cell division in the POA/hypothalamic population. There is also a
pronounced sex difference in the POA/hypothalamus with males having more mast cells than females but there
is no evidence to-date of the same in the hippocampus. We seek to understand the tissue origins, proliferative
capacity and functions of both populations with three independent but inter-related specific aims. Aim 1 will test
whether mast cells originate in the canonical source, the bone marrow, versus the yolk sac versus a newly
identified hematopoietic niche in the skull. Aim 2 will test the hypothesis that c-kit (stem cell factor) regulates
the differential capacity of mast cells in the POA/hypothalamus versus hippocampus. Additional candidates will
be identified by transcriptional profiling of the two populations. Aim 3 will establish the functional impact of mast
cell activation in each region with an emphasis on modulation of neighboring microglia and neurons, opening of
the blood:brain:barrier and peripheral immune cell influx A model of maternal allergy will provide a naturalistic
stimulus and comparative source of mast cell degranulation. Completion of these aims will identify a novel source
of vulnerability to early life inflammation during a critical period in brain development and highlight nodes for
therapeutic intervention and prevention.

Public health relevance
Neurodevelopmental disorders have devastating and lasting consequences and are more likely in males and individuals experiencing inflammation early in life. Mast cells are an innate immune cell that reside in the brain and contribute to both normal development and inflammation, but how these roles are manifest is poorly understood and the goal of the proposed studies